SUPPORT OF OCCUPATIONAL STUDIES

The purpose of this contract is to provide technical, managerial and clerical support for occupational studies directed by the Occupational Studies Section (OSS), EEB, EBP, DCE, NCI. The Contractor shall function in a supportive role carrying out specific tasks and will not engage in independent research. The terms "designing" or "developing" used in this contract refer to the completion of tasks specified and monitored by NCI in a support contract.